The role of ENL mutations in kidney development and tumorigenesis

Project Summary
Wilms tumor is the most common pediatric renal tumor, primarily affecting children under the age of 5. It is closely
linked to disrupted nephrogenesis and features rudimentary structures found in the developing kidney. While
alterations in transcription factors and signaling proteins crucial for kidney development are known molecular
drivers, recent studies have revealed that 30-50% of Wilms tumor patients have mutations in epigenetic
regulators, with ENL (Eleven-Nineteen Leukemia) being the most frequently mutated. The role of these
epigenetic regulators in kidney differentiation and tumorigenesis remains unexplored. This study aims to fill this
gap by exploring the role of ENL mutations in nephrogenesis and Wilms tumor development. ENL is a chromatin
reader protein which binds histone acetylation through its YEATS domain to recruit co-factors and drive
transcriptional elongation. Hotspot mutations in the ENL YEATS domain have been identified in Wilms tumor.
These mutations result in hyperactivation of target gene transcription by the formation of high local concentration
assemblies termed condensates. To study the role of ENL mutations in Wilms tumor, our lab developed a
conditional knock-in mouse model for the most frequent Enl mutation, referred to as Enl-T1. We crossed these
mice to the Wt1-Cre strain to induce heterozygous expression of Enl-T1 in the nephron and stroma lineages of
the developing kidney. These mice displayed aberrant kidney development with the loss of differentiated nephron
structures and post-natal lethality. Single-cell analyses of transcriptomics and open chromatin accessibility
revealed that Enl-T1 shifts nephron progenitor cells toward an aberrantly committed state while restricting their
further differentiation. Enl-T1 expression also disrupted stromal progenitor cell differentiation, suggesting a role
for ENL in both stromal and nephron progenitor populations. Notably, the developmental defects and
transcriptional changes induced by Enl-T1 can be rescued by treatment with TDI-11055, an inhibitor that blocks
the interaction of ENL-T1 with acetylated histones. Based on these findings, I hypothesize that an optimal level
of ENL activity is critical for normal kidney development, and disruptions to this balance through gain-of-function
mutations in ENL can lead to tumor formation. I will investigate the role of the Enl-T1 in nephrogenesis and
tumorigenesis using lineage specific cre drivers (Aim 1) and determine the impact of the ENL mutant inhibition,
using TDI-11055, on Wilms tumor maintenance (Aim 2) through a combination of mouse modeling, histological
analysis, single cell transcriptomics, and patient-derived Wilms tumor organoids. These studies will elucidate the
role of Enl mutations in kidney development and disease, identify a novel therapeutic target in Wilms tumor, and
provide new insights into how epigenetic regulation plays a role in cell differentiation in normal and diseased
contexts.

Public health relevance
Project Narrative Wilms Tumor is the most common pediatric kidney cancer and is linked to disrupted kidney development. Recent studies have found that 30-50% of Wilms tumor patients harbor mutations in epigenetic regulators, with chromatin reader protein ENL being the most frequently mutated. Investigating the role of ENL mutations in kidney development and Wilms tumor will provide novel insights into epigenetic mechanisms that regulate tumorigenesis and provide a proof-of-concept for a therapeutic strategy of targeting epigenetic regulators in Wilms tumor.